Single-Cell-Resolved Mapping and Evolution-Driven Functional Interrogation of Human Midface Enhancers

SUMMARY
Developmental anomalies of the midface, including clefts of the lip and palate, are a common feature of
congenital disorders. They can substantially impact respiration, feeding, speech, and social connection, and
often require stressful and expensive surgical interventions in affected children. Despite their clinical importance,
the genetic basis of most midface defects remains unclear due to our limited understanding of the genes
involved, as well as their cell type-specific regulation in time and space during human face development. This
proposal will generate resources to address the current lack of a cell type-resolved understanding of gene
regulation in human midface development and apply these findings for in-depth computational and experimental
studies of individual enhancers involved in human midface development. We propose to generate a single-cell
multimodal atlas of human craniofacial development, followed by evolution-driven comparative analysis to
prioritize enhancers likely to affect midface development, and detailed hypothesis-driven interrogation of
enhancers using transgenic and knock-in mouse models. First, we will apply a suite of state-of-the-art
multimodal single-cell assays to human craniofacial tissues at stages critical for midface development.
This will include single-cell assays developed by the investigators and uniquely available in their laboratories.
Using a data integration strategy demonstrated in preliminary studies, this will provide a detailed atlas of the
transcriptome and enhancer landscape at cell type resolution, including the genomic location of enhancers, their
activity states (poised or active), and their 3D interactions with target promoters. This information cannot be
gained from currently available bulk tissue-derived human data but is critical for studies of enhancers affecting
human midface development. Building on this unique resource, we will use the substantial diversity in
midface morphology present in hundreds of mammalian species with sequenced genomes to identify
enhancers that show accelerated evolutionary sequence signatures that correlate with recurrent
changes in midface morphology. Intersecting such evolutionary signatures with cell type-resolved maps of
human midface enhancers will identify high-confidence candidate midface enhancers at loci implicated in human
midface variation and birth defects. Finally, we will use mouse transgenic assays, single-cell reporter assays,
and knock-in enhancer replacement engineering, to validate predicted enhancers in vivo, characterize
their activity in craniofacial development, and study their impact on midface development through
landmark-based 3D morphometrics of knock-in mice. We will reserve a proportion of our transgenic and
mouse engineering capabilities under this proposal to support ongoing collaborative studies with promising initial
data, as well as new nominations from the community. Consistent with our commitment to community support
and FAIR data principles, we will make all data from this proposal available to the craniofacial community through
FaceBase, with which Dr. Visel has been continuously involved since its inception.

Public health relevance
NARRATIVE The human face is a critical component of personal identity, and birth defects of the face cause major psychosocial, speech, feeding, and breathing problems and require costly and stressful surgical correction. The development of the face requires the precise activation of genes, a process that is orchestrated by noncoding DNA sequences called enhancers. To help researchers understand how disruptions of genetic and cellular components required for facial development cause birth defects, we will use a set of advanced functional genomics tools to generate an atlas of enhancers and gene activation for human face development, describing the process at the resolution of single cells.